Mentoring Investigators on the Clinical Translation of Cardiometabolic Genetic Discoveries

ABSTRACT
We have entered a new era in which the explosion of genomic and biological information
across multiple developmental and metabolic states is poised to transform the practice of
medicine. The clinician’s ability to absorb, assimilate and translate this information will
determine the extent of its impact on public health. There is an urgent need to train clinical and
non-clinical scientists who are competent on big biological data, and who can curate,
disseminate and implement the clinically actionable findings that emerge from ongoing efforts.
The PI on this application has dedicated himself to advance genomic and metabolomic
discoveries in type 2 diabetes and related metabolic traits, and during the first funding cycle of
this award generated resources and established a training pipeline at the Massachusetts
General Hospital (MGH) and Broad Institute. He now seeks to continue attracting and mentoring
a cadre of highly trained investigators who will be enabled and empowered to lead the
application of genomic and systems-wide approaches to the clinical setting. To achieve this
goal, he will 1) expand the infrastructure of pertinent genomic and physiologic datasets available
for mining, 2) maintain a rigorous yet nurturing training pipeline of carefully selected mentees,
and 3) guide the investigation of clinically relevant hypotheses that can be tested in the ideal
environment. Dr. Florez is embedded in a successful and productive milieu that embraces a
culture of collaboration. As the Chief of the Endocrine Division and member of the Center for
Genomic Medicine at the MGH and an Institute Member at the Broad Institute, he is placed in a
unique position that will enable him and his trainees to benefit from direct access to an
unparalleled suite of training resources and datasets germane to the proposed patient-oriented
research in cardiometabolic disease.

Public health relevance
NARRATIVE The explosion of genomic and biological information is poised to transform the practice of medicine, but its impact will be determined by the clinician’s ability to absorb, assimilate and translate this body of knowledge. Dr. Florez has dedicated himself to advance genomic and metabolomic discoveries in type 2 diabetes and related metabolic traits, and previously generated useful resources and established a training pipeline. He now seeks to continue attracting and mentoring a cadre of highly trained investigators who will be empowered to lead the application of these findings to the clinical setting, by 1) expanding an infrastructure of pertinent genomic and physiologic datasets, 2) maintaining a rigorous training pipeline embedded in a cutting-edge clinical and scientific environment, and 3) guiding the investigation of clinically relevant hypotheses.